Defining the mechanisms regulating adipose tissue metabolic memory and its role in rebound weight gain.

Obesity is one of the most pressing public health challenges of the 21st century. Weight gain occurs in the
setting of nutrient excess, which stimulates adipose tissue expansion via both healthy hyperplastic and
pathologic hypertrophic processes. The metabolic consequences of obesity, including diabetes and fatty liver
disease, stem from a relative deficiency in hyperplastic expansion of adipocyte progenitor cells. GLP1
medications have drastically changed the therapeutic landscape, enabling millions of patients to achieve
significant weight loss, however much remains to be learned about the pathophysiology of obese and post-
weight loss adipose. Using single-cell sequencing we identified a population of maladaptive FAPs arising in
obese adipose as well as an anatomically-distinct population of connective-tissue-resident macrophages
marked by Lyve1. Preliminary data indicate that the Lyve1+ macrophages serve as niche-defining cells that
maintain FAP homeostasis in lean adipose, however their number are diminished in obesity. Genetic depletion
of Lyve1+ macrophages leads to pathologic lineage allocation of maladaptive FAPs, that express a
transcriptional profile analogous to obesity-induced FAPs, including the matrix-modifying genes such as Timp1.
We discovered corresponding ECM stiffening and decreased compositional diversity in obesity using highly
precise rheological quantification and ECM proteomics of mouse and human adipose. We developed a tunable
ex vivo 3D collagen hydrogel model and found that FAP adipogenic differentiation capacity is tightly regulated
by ECM biomechanics. Most notably, many of the cellular changes and ECM properties induced by obesity
persist following weight loss. The Aims of this grant are to: (1) Determine the role of Lyve1+ macrophage in
directing the lineage allocation of maladaptive FAPs in obesity and weight loss. (2) Characterize the activity of
FAP-expressed Timp1 in maladaptive ECM remodeling and its consequences for post-weight loss adipose
physiology. To attain these objectives, we will utilize novel mouse models, advanced transcriptomic
techniques, metabolic and biomechanical phenotyping to investigate of the mechanisms regulating the
development of adipose ECM-encoded “metabolic memory” of previous obesity that persists despite
subsequent weight loss. This work will address long-standing questions in the field regarding adipose-intrinsic
cellular and molecular mechanisms promoting rebound weight gain.

Public health relevance
GLP1 medications have enabled millions of patients to achieve significant weight loss, however their practical use is complicated by significant rebound weight gain when treatment is interrupted. The cellular and structural changes occurring within post-weight-loss adipose that contribute to this rebound weight gain are poorly understood. Through the study of obesity-imprinted changes within adipose-resident cell populations and consequent maladaptive remodeling of the adipose extracellular matrix, this innovative project will provide important insights into the mechanism underlying adipose tissue metabolic memory and its role in weight regain and metabolic disease.